Re-Wiring the Human Brain

PROJECT SUMMARY / ABSTRACT
Behaviors and mental functions are emergent properties of large-scale neuronal networks where connectivity
strengths between nodes define the network. Correspondingly, many neurological and psychiatric symptoms
arise from network-level imbalances where structural and/or functional connectivity between specific brain areas
has been altered (e.g., sub-cortical stroke, traumatic brain injury TBI). For structural injury, while the adult brain
has little capacity to re-grow damaged long-range axons, it may be possible to restore connectivity by training
the brain to use alternate routes reconnecting the areas and/or counteracting maladaptive connectivity changes,
with the goal of improving motor/behavioral/cognitive function. This also applies to disorders without structural
injury but with acquired pathological connectivity changes (e.g., addictions, depression). To restore the network
in a controlled fashion, there is a critical need to develop techniques that can selectively engage the targeted
connection and increase or reduce its effective connectivity strength. Moreover, the techniques should be appli-
cable to the human brain and ideally be non-invasive. To this aim, cortico-cortical paired associative stimulation
(ccPAS) protocols have been proposed, presumably engaging spike timing-dependent plasticity (STDP) mech-
anisms. However, progress in applying ccPAS in humans has been limited. This is because millisecond-precision
intracranial conduction delays, which are a prerequisite for choosing ccPAS parameters that would have the
desired effect, are not known. Further, neurophysiological outcome measures to capture intracranial ccPAS ef-
fects are lacking, which makes it difficult to assess if the stimulation achieved its goals – in fact, it has not even
been convincingly shown if ccPAS engages STDP. The overall goal of the proposal, therefore, is to overcome
these barriers by (a) crafting novel techniques that can measure the required fast intracranial conduction delays,
(b) developing outcome measures that capture ccPAS neurophysiological effects accurately, and (c) proving
ccPAS mechanisms. Specifically, inspired by previous animal and human studies, as well as our own preliminary
ccPAS data, we will stimulate two interconnected cortical regions with millisecond-level asynchronies with two
independent transcranial magnetic stimulator (TMS) coils. Our preliminary data show source-space cortico-cor-
tical evoked potentials (ccEP) that capture both the required conduction delays and serve as outcomes of ccPAS
effects at the physiologically relevant fast (<10 ms) timescales. Further, our preliminary data that parametrically
manipulates ccPAS asynchronies are in accord with that the mechanism is indeed STDP. If successful, this
study will transform our capability to non-invasively manipulate brain interregional effective connectivity in the
human brain, therefore laying the foundation for a new class of robust network-level therapies in disorders that
involve brain connectivity changes in a broad range of neurological and psychiatric disorders.

Public health relevance
PROJECT NARRATIVE Our overall goal is to develop non-invasive brain stimulation/recording techniques for the human brain that can selectively up- or downregulate a specific connection between two brain areas as well as record the conduction delay and connectivity strength between them. This is useful, because many brain-related disorders reflect net- work-level changes where the connectivity strengths between specific areas have been pathologically reduced or increased. The techniques will be applicable to clinical and research applications in a wide spectrum of neu- rological and psychiatric disorders.